Mapping Neurocognitive Complications of Pediatric Type 1 Diabetes (T1D) and Potential Risk and Protective Factors

PROJECT SUMMARY
The pathophysiology of cognitive dysfunction in prepubertal children with Type 1 Diabetes
Mellitus (T1DM) is not understood. It is likely that hyperglycemia, hypoglycemia, vascular
disease, insulin resistance, and diabetic ketoacidosis (DKA) play important roles. However, the
absence of longitudinal studies in T1DM children and our lack of understanding of the
pathogenesis of neuronal defects limit our ability to prevent cognitive disability and identify and
treat those at highest risk. Despite preliminary evidence that T1DM is associated with alterations
in brain structure and function, major gaps remain in our knowledge about how T1DM impacts
the developing brain.
The overall premise of this project is that T1DM in children is associated with significant
neurocognitive and brain alterations and the risk of developing neurocognitive deficits
increases with both biological and psychosocial stress that ultimately delay/impede the
normal maturation of associative brain systems supporting attention, learning and
memory, executive and social cognition. Our hypothesis is that children with greater net
exposure to biological and psychosocial stress will have greater deficits in trajectory of brain
development underlying complex cognition.
Our multidisciplinary team of neuroimaging experts and endocrinologists will examine brain and
cognitive alterations in children with T1DM across three aims: Aim 1 will measure the
differential impact of age of T1DM diagnosis on brain structure, micro-organization, metabolism
and function and mental health. Aim 2 will Identify biological and psychosocial moderators and
Risk and Resilience factors. We will evaluate the impact of both biological stressors and social
determinants of health (e.g., SES, Education, Adversity exposure, rurality, access to healthcare
services, race, etc.) on neurocognitive function and maturation in children with T1DM. In Aim 3
we will develop a recruitment, retention and dissemination strategy to prepare for future clinical
trials that build a precision risk- and resilience-prediction model.
The findings from this observational study will bridge gaps in our understanding of the
development of neurocognitive dysfunction in T1DM. It will further inform key clinical targets to
address to ensure the optimal care of children with T1DM. The power of a larger network will
further allow the exploration of complex 2-way or even 3-way interactions between biological
and social determinants of health and neurofunctional outcomes in children with T1DM.

Public health relevance
NARRATIVE Type1 Diabetes Mellitus (T1D) affects an estimated ~150,000 youth in the U.S., with ~18,000 youth diagnosed annually, yet much remains unknown about the clinical, developmental, and environmental effects of T1D on neurocognitive function. This proposal will establish a UNC clinical research center to participate in the T1D consortium to evaluate the neurocognitive complications of pediatric T1D and identify potential risks and protective factors that affect brain and cognitive development trajectories in children with a first-time diagnosis of T1D. The project will contribute to a multi-site clinical research infrastructure to recruit and retain children and families with T1D through stakeholder engagement and effective dissemination, and will develop predictive models integrating multimodal brain, behavior and clinical data to assist in risk stratification and development of effective targeted early interventions and clinical care practices.